Structure-Function Studies Of IP3R Channels

Project Summary/Abstract (parent award) Ca2+ release from internal stores is mediated by inositol 1,4,5-trisphosphate receptors (IP3R) that belong to a family of intracellular Ca2+ channels localized to the endoplasmic reticulum membranes in almost every cell type. The rapid flux of Ca2+ through IP3R channels is central to numerous and markedly different cellular actions, ranging from contraction to secretion, from proliferation to cell death. Dysfunction of IP3Rs is implicated in numerous neurodegenerative diseases, such as Alzheimer’s and Huntington’s disease, cardiac arrhythmias, autoimmune disease, ataxia, stroke and cancer. Despite established significance of IP3Rs in physiology and pathology, the molecular mechanisms underlying function of these channels, both in native and disease states, remain poorly understood. This is mainly due to the lack of atomic-level details of IP3R structure. The long-term goals of our research are to understand the mechanisms of ion permeation and gating in the family of IP3R channels, and how intracellular binding partners regulate the channel function. The focus of this proposal is neuronal type 1 IP3R (IP3R1), the predominant type of IP3-gated Ca2+ release channel in cerebellar Purkinje cells. This proposal builds on extensive advances we made recently in structural studies of this ion channel. We aim to uncover high-resolution architecture of IP3R1 and to delineate conformational changes in the channel that underlie its gating motion and regulation by an array of intracellular molecules ranging from ions and small chemical compounds to proteins. Our research efforts will include cryo-EM structure determination, biochemistry, biophysical, mutagenesis and electrophysiological studies to address channel structure-function Built upon the complementary expertise of established investigators with compelling preliminary data support, the proposed studies will unveil the structural and mechanistic basis for IP3R1 function and will elucidate how defects in mechanisms regulating the channel’s gating can lead to abnormal cell Ca2+ levels underlying numerous diseases. Our research is innovative since little is known at the atomic level about the IP3R function. With these studies accomplished, we will establish a detailed structural framework for understanding how the IP3R selectively senses and decodes multiple ligand-binding signals into gating motions that enable the passage of Ca2+ through the channel. This knowledge is crucial for developing new ways to control channel function. Overall, the proposed studies are highly significant, as they will provide valuable mechanistic insights into Ca2+ transfer across biological membranes illuminating the pathological consequences of deregulated Ca2+ signaling, that will ultimately aid in search for novel therapies targeting the IP3R channel family.

Public health relevance
Project Narrative (parent award) Inositol 1,4,5-trisphosphate receptors (IP3Rs) belong to a family of intracellular calcium channels that are ubiquitously expressed in all tissues and play central roles in maintenance and regulation of cell calcium homeostasis. Dysfunction of IP3Rs is linked to numerous human diseases, including stroke, neurodegenerative diseases and cancer. This proposal aims to understand the detailed structure and mechanisms of IP3R channel that will contribute to the development of new therapies for treatments of disorders related with abnormal cell calcium homeostasis.